Integrative models of nuclear DNA organization

Project Summary/Abstract
The human genome organization inﬂuences gene regulation. Aberrant nuclear structures observed in cancer and
conservation of common features of genome organization, such as A/B compartments, topologically associated
domains, and loops across mammalian evolution, further hint at its role in gene regulation. Yet scientists are only
beginning to understand the sequence determinants and regulatory implications of nuclear DNA organization.
Next-generation sequencing assays such as Hi-C, ATAC-seq, and RNA-seq assist in this task by measuring
genome-wide biochemical activities. However, each of these three assays provides only a partial snapshot of
regulatory interactions, and the lack of successful integration has hindered our understanding of the impact of
nuclear organization on critical biological functions.
The overarching goal of this proposal is to identify the functional consequences of variations in nuclear archi-
tecture on transcriptional and post-transcriptional regulation and the role of this variation in human health and
disease. Speciﬁcally, Aim 1 proposes to identify the sequence determinants of Hi-C contacts using novel deep
learning models that predict Hi-C contacts from nucleotide sequences across 80 human tissues (K99 phase).
Additionally, Aim 2 proposes to learn the rules of chromatin organization shared across evolution using a deep
learning model for translating between Hi-C and ATAC-seq across 100 mammalian species (K99 phase). Finally,
Aim 3 proposes to model the impact of variations in the nuclear organization on tissue-speciﬁc transcriptional and
post-transcriptional regulation in humans using machine learning, long-read RNA-seq, and Hi-C (R00 phase).
Together, this work will provide novel, open-source, and interpretable machine learning models to enable the
discovery and quantiﬁcation of the regulatory causes and functional consequences of nuclear DNA organization in
healthy human tissues and misregulation of this architecture in disease. The models, resources, and skills learned
during Aims 1 and 2 (K99 phase) will be used to accomplish Aim 3 during the R00 phase. The candidate aims
to establish an independent research program that bridges the gap between experimental and computational
research into genome architecture and gene regulation. She will receive the interdisciplinary training needed
from her mentor, Dr. William Noble and her postdoctoral advisory committee, Drs. Erez Lieberman Aiden, William
Greenleaf, Anshul Kundaje, and Sheng Wang. In addition, she will participate in career development activities
offered through the University of Washington. Her research training, mentor, advisory committee, and academic
environment will prepare her well as she transitions to an independent position as an academic researcher.

Public health relevance
Project narrative Nuclear DNA organization is deliberate. It inﬂuences transcriptional regulation, and structural deviations are associated with cancers and congenital developmental disorders. The goal of this proposal is to elucidate the sequence determinants of 3D genome folding across human tissues and mammalian species and model the impact of genome folding on epigenetic regulation, gene expression and alternative splicing.